Integrated Microscopy Core Facility

Abstract
The research of Wyoming Sensory Biology Center (SBC) involves imaging of the nervous system in vivo and
visualization of the regional distribution and concentration of proteins and transcripts associated with the
development, aging, and function of the sensory and nervous systems. The University of Wyoming
Microscopy Core has been built using the funds of the previous IDeA grants. During COBRE Phase I, the Core
has provided support to researchers from 16 SBC labs and 32 non-SBC labs. The Core has been significantly
expanded in space and scope. In response to the requests of the SBC members, the Core has acquired four
new state-of-the-art microscopes and nine new pieces of molecular analysis instrumentation, primarily for the
transcriptome and genome analysis. To reflect the expanded scope of services, the Core has been renamed
Integrated Microscopy Core (IMCore). It is now comprising the Jenkins Microscopy Facility (JMF) and the
Molecular Analysis Unit (MAU). The Phase I grant allowed SBC to leverage the expertise of the Core Director,
Dr. Zhang, who holds a full-time, university-funded position. Dr. Zhang's leadership has been essential for
sustaining the IMCore operations and for overseeing its expansion during the COVID-19 pandemic. The
IMCore has made significant contribution to success of the SBC investigators, as evidenced by their increased
research productivity, higher success in obtaining external funding, broader IMCore usage, and increased
collaborations with non-SBC biomedical researchers at UW and seven Wyoming community colleges. The
overarching goal of COBRE Phase II is to enhance the ability of SBC investigators and other biomedical
researchers in Wyoming in their research pursuits. The following two specific aims are proposed for COBRE
Phase II. Aim 1. To improve the organization of the IMCore and to expand the service capabilities in
microscopy imaging and transcriptome and genome profiling of the sensory and nervous systems. Aim 2. To
optimize the operational efficiency and enhance the long-term self-sustainability of the IMCore. Completion of
these aims will help the IMCore: (1) to meet technical challenges and enable innovative research by SBC
investigators, (2) to foster new and strengthen existing collaborations among SBC investigators, and (3) to
prepare for long-term Core self-sustainability.